Retinal biomarkers in monogenic vascular cognitive impairment and dementia

Project Summary/Abstract
The project will enroll 180 persons with the autosomal dominant gene for Cerebral Autosomal Dominant
Arteriopathy with Subcortical Infarcts and Leukoencephalopathy (CADASIL) to investigate retinal imaging
measures as potential diagnostic, prognostic, and disease monitoring biomarkers for clinical trial readiness.
CADASIL is a rare disease and the most heritable monogenic form of vascular cognitive impairment and
dementia. The research design will allow the examination using the full spectrum of vascular dementia from
presymptomatic gene carriers through dementia. This research is novel from any other in its efforts to study a
single-gene vascular dementia group throughout the life span in an effort to reduce vascular dementia
heterogeneities selecting persons enriched for certain future vascular disease secondary to NOTCH3 gene
mutation. CADASIL has been considered a good single-gene model of small vessel disease and vascular
dementia. By improving our understanding of CADASIL and its progression, we will be better able to
understand the more common sporadic vascular dementias. Since many known neurodegenerative diseases
are determined at autopsy to be mixed dementias with a vascular component, the findings from the proposed
research may also impact the large cohorts of neurodegeneration in our aging population. We have
established an NIH-funded U.S. multi-site longitudinal natural history study of CADASIL (www.cadasil-
consortium.org). The proposed grant aims to build on this ongoing CADASIL study by adding multifaceted
retinal imaging to investigate as a biomarker in CADASIL. Studying the retina – a region that shares numerous
embryological and anatomical similarities with the brain – will advance our understanding of various
pathologies caused by different NOTCH3 pathogenic variants (PVs). The retina's structural and vascular
features can be demonstrated non-invasively with high resolution optical coherence tomography (OCT) and
OCT-angiography (OCT-A). In this project, we will focus on three primary retinal assessments: 1) retinal
capillary bed pathology using OCT-A with measures of vessel density (VD), foveal avascular zone (FAZ)
area/effective diameter, vessel tortuosity index (VTI); 2) retinal arteriolar changes using spectral domain (SD)
OCT with measures of mean wall thickness (MWT) and lumen diameter (LD) of the superior temporal retinal
arteriole; and 3) inner plexiform layer (IPL) thickness as a measure of synaptic injury. At the conclusion of this
research, data will be available to determine the strength of each potential measure as a biomarker for clinical
trials in neurodegenerative diseases with cerebrovasculopathies. Findings will facilitate determination of the
contexts of use for non-invasive, low-cost retinal imaging biomarkers.

Public health relevance
Project Narrative This research project aims to study 180 persons from families with the rare genetic disease named CADASIL. Images of the retina will be obtained and analyzed using both traditional and novel methods to develop new potential measures of CADASIL that would be useful in clinical trials to select participants for study, to determine whether and when a treatment is working, and to better understand the underlying mechanisms of CADASIL.